Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative Core for the Vanderbilt Antibody and Antigen Discovery for Clostridioides difficile
Vaccines (VANDy-CdV) program will serve to integrate and facilitate the broad range of activities that will be
undertaken within the program. This core will benefit from considerable administrative leadership experience
among the team members as well as strong institutional support. Four specific aims/responsibilities are
proposed. The first aim will be to coordinate program activities. The success of VANDy-CdV will depend on
frequent and meaningful interactions between all investigators. A Local Steering Committee composed of project
leaders, core directors, and key personnel will meet monthly to monitor progress, guide scientific directions, and
to monitor finance- and compliance-related issues. In addition, a full team meeting will occur quarterly to foster
productive and collaborative research. All VANDy-CdV members will be invited to share progress and solicit
constructive feedback. The Administrative Core will plan, coordinate, and document the activities from these
meetings. The second aim will be to interface with NIAID Program Officers and ensure that NIH reporting
requirements are met. In addition to official reporting requirements, the Administrative Core will notify the NIH of
all VANDy-CdV monthly and quarterly meetings. The Core will generate reports following each meeting and
distribute these reports to Local Steering Committee leaders and NIAID Program Officers. The Administrative
Core will also coordinate travel for VANDy-CdV members to attend and participate in Annual Programmatic
Meetings. The third aim is to provide fiscal oversight. Vanderbilt University Medical Center is ultimately
responsible for all spending decisions involving VANDy-CdV; however, the initial level of fiscal oversight will be
the responsibility of the Administrative Core. The fourth aim is to manage intellectual property, resource and
reagent distribution, and transmittal of data to public databases. Opportunities relating to intellectual property
across the projects and cores will be handled by the Administrative Core in conjunction with the Vanderbilt Center
for Commercialization and Technology Transfer (CTTC). The Administrative Core also will ensure that all
reasonable requests for reagents from any VANDy-CdV program are satisfied within a timely manner.